Improving Maternal and Child Health in the Year After Birth: An Early Evaluation of Postpartum Medicaid Eligibility Extensions

PROJECT SUMMARY
State Medicaid programs pay for nearly half of all births in the United States (U.S.), financing over 1.6 million
births in 2019. Federal law requires states to provide pregnancy-related Medicaid coverage to low-income
pregnant individuals through 60 days postpartum, after which 1 in 4 become uninsured. A substantial and
increasing proportion of adverse pregnancy-related outcomes, including maternal morbidity and mortality, are
occurring among individuals with Medicaid-paid births and after pregnancy-related Medicaid coverage ends.
Postpartum Medicaid eligibility extensions (PMEs) to one year postpartum are an emerging strategy for
improving insurance enrollment, healthcare access, and health for low-income mothers and children. Passed in
response to the COVID-19 Public Health Emergency, two federal laws have accelerated implementation of
PMEs. First, the Families First Coronavirus Response Act (FFCRA) of March 2020 prevented states from
disenrolling Medicaid beneficiaries during the public health emergency. In turn, the FFCRA created a
national de facto PME. Second, the American Rescue Plan Act (ARPA) of March 2021 allows states to adopt
PMEs starting in April 2022 with federal matching funds. Rigorous evaluations of these policies are urgently
needed to inform state decisions to adopt PMEs and determine whether these polices are having the intended
effect of improving maternal, child, and pregnancy-related health in the year after birth.
To inform ongoing, evidence-based policymaking and fill this significant gap in maternal and child health
research, our multi-disciplinary team will conduct rigorous, quasi-experimental evaluations that exploit state
variation in policy adoption to provide timely data on the FFCRA and ARPA and associated changes in 1)
maternal insurance enrollment, healthcare use, and health; 2) children’s insurance enrollment, healthcare use,
and health; and 3) outcomes among subsequent pregnancies including rates of short interpregnancy interval
and preterm births (NOT-HS-14-004). Given that a disproportionate share of those with Medicaid-paid births
and experiencing adverse health events in the postpartum year are low-income and Black, Indigenous, or
people of color (AHRQ priority populations), we will also measure the impact of PMEs on racial health equity
(NOT-HS-21-014).
The proposed set of evaluations will produce data directly informing whether these unprecedented, large-scale
policy interventions have been associated with improvements in maternal and child health or racial and ethnic
disparities in the year after birth. We will generate timely findings to inform ongoing, evidence-based
policymaking to address the U.S. maternal health crisis. Ultimately, we aim to improve health and reduce
disparities in the year after birth among low-income mothers and children at the population level.

Public health relevance
PROJECT NARRATIVE High levels of postpartum uninsurance among individuals with Medicaid-paid births contribute to rising rates of maternal morbidity and mortality in the United States. Passed in response to the COVID-19 Public Health Emergency, the Families First Coronavirus Response Act (FFCRA) and the American Rescue Plan Act (ARPA) allow for federal (FFCRA) and state (ARPA) extensions of pregnancy-related Medicaid eligibility through the first year postpartum. Our study will produce data of high scientific value to inform whether these large-scale interventions are an effective tool for improving maternal and child health and racial health equity in the year after birth.